Project 2: Development of Rapid, Miniaturized Biosensors

It is the goal of this project Biosensors, to apply new and emerging technologies to implement bioassays that our colleagues at Davis have developed, with improvements in speed and/or sensitivity compared to conventional methods. Several new schemes for detection will be tested, including a nanowell format for trapping and interrogating our non-bleaching nanoparticle labels for DNA and immune assays;a magnetic/luminescent nanoparticle format for DNA assays;and a nanostructured liquid core waveguide for enhancement of fluorescence detection. The targets will include the pyrethroid metabolite 3-PBA, emerging problem compounds such as TCC, TCS and PBDE, and genes for microbes that are used in bioremediation activities. A sensor for TCDD and related compounds will be developed based on AhR technology.

Public health relevance
Monitoring the release of toxic compounds from Superfund sites and the exposure of vulnerable populations is crucial to ensuring the health of the environment and humans. Furthermore, it is important to monitor the success of clean-up efforts such as bio-remediation and to assess the potential for toxic compound release during the operation of chemical methods such as thermal remediation. The Biomarker projects at UC Davis have developed a range of techniques for measuring the presence of toxins in air, water and soil samples, and as human metabolites; this project will take the next step in implementing the assays in new formats that can be applied to real-world problems of environmental monitoring.